VASCULAR RESISTANCE IN PATIENTS WITH SLEEP APNEA EXPOSED TO HYPOXIA

To test the hypothesis that patients with sleep apnea have abnormalities of the peripheral circulation by testing the response of forearm vessels to hypoxia and ischemia.